B-cell response and thrombotic complications in COVID-19

Abstract
COVID-19 severity/lethality is associated with a dysfunctional inflammatory immune response and a hyper-
engagement of pathways driving hemostasis and thrombosis, but the link between the two manifestations is not
understood. Compared to patients with mild symptoms, severe COVID-19 patients have stronger IgG reactivity
to SARS-CoV-2 virus and its spike protein receptor binding domain (RBD) and a robust B-cell response with a
marked increase of the CD11c+CD21- B cells and plasmablast compartments. The incidence of thrombosis and
inflammatory disease in severe COVID-19 is unprecedented, manifested by increased plasma inflammatory
markers, such as IL-6, tumor necrosis factor alpha, C-reactive protein, and activation of compliment pathway
etc., and dysregulated activation of cellular components participating in inflammatory and coagulation responses
that include platelets, endothelial, monocytes, and neutrophils. The thrombotic manifestation ranges from
arterial, venous, and tissue micro thrombosis to thromboembolism and is predominated by venous
thromboembolism. Similar manifestations are observed in catastrophic thrombosis associated with heparin-
induced thrombocytopenia and thrombosis (HIT). Patients with catastrophic HIT have the sudden onset of
multiple arterial and venous thrombi with, but sometime without, heparin exposure, due to prothrombotic platelet-
activating IgGs that recognize platelet factor 4 complexed with heparin polysaccharide (PF4/H). Using methods
employed in previous studies of HIT, we studied patients with severe COVID-19 patients and identified PF4/H-
reactive, pro-thrombotic IgG antibodies that closely resemble pathogenic antibodies found in patients with HIT
in their ability to activate platelets. Surprisingly, levels of PF4/H antibodies in the patient plasma correlated with
levels of antibodies specific for the receptor binding domain (RBD) of the SARS-CoV-2 spike protein. We cloned
RBD-specific antibodies that are able to activate platelets. Compared to those that recognize RBD alone,
significantly more B cells recognizing both RBD and PF4/H were CD11c+, CD21- and CXCR3+, which mark a
subset of extrafollicular B cells robustly expanded in severe COVID-19. Based on these findings, we hypothesize
that SARS-CoV-2 infection drives a subset of RBD-specific B cells to respond via an extrafollicular
pathway and generate platelet-activating antibodies that contribute to thrombotic complications but not
virus neutralization in severe COVID-19. To test our hypothesis, we will 1) investigate the prothrombotic
activity of RBD-specific antibodies in the plasma of hospitalized COVID-19 patients; 2) investigate the expansion
of B cells that make RBD-specific platelet-activating antibodies in severe COVID-19; 3) investigate the
developmental pathway that governs affinity maturation of RBD and PF4/H cross-reactive B cells. Our proposal
studies a novel B-cell/platelet axis in thrombotic complications in COVID-19 and should unravel a large portion
of the complex pathogenesis of morbidity/mortality in this disease and suggest new treatment.

Public health relevance
Project Narrative Thrombotic complications are associated with increased severity and mortality in coronavirus disease 2019 (COVID-19). The proposed studies aim to understand the molecular mechanism underlying these thrombotic complications and may help to identify novel approaches to control severity and mortality associated with COVID- 19.